Regulation of vasculature by estrogen receptors during aging in mouse models

DESCRIPTION (provided by applicant): Angiogenesis is a process of new vessel formation from pre existing capillaries or venules. It has been reported that this process is impaired in aged tissues. The changes in angiogenesis that occur with aging have been documented at the molecular, cellular, and physiological levels of regulation. The steroid hormones are among the factors that have been shown to have influence on the neovascularization process. Estrogen is one of the steroid hormones which has been suggested to promote new vessel formation. However, regulatory mechanisms underlying the action of estrogen on endothelial cell function and angiogenesis are not fully understood. The action of estrogen is mediated through the estrogen receptor α (ERα?) and/or estrogen receptor β (ERβ?). In our study we investigated the role of estrogen receptors in the process of new vessel formation using female ERα? and ERβ? knockout mice. Our preliminary data have demonstrated an impairment of skin microvasculature in both ERα? -/- and ERβ? -/- mice. Moreover, mRNA levels of several genes involved in the regulation of vessels stabilization such as PDGFB, VE-cadherin, N-cadherin were downregulated in the endothelial cells isolated from ER ? -/- mice. Furthermore, we observed increased collagen synthesis in the ER ?-/- mice, while a decrease was observed in ER?? -/- mice. Interestingly, two proteoglycans, Lumican and Decorin were increased in the skin of ER?? -/- mice, while their decrease was observed in the skin of ER?? -/- mice. These results may indicate an opposite regulation of these ECM components by estrogen receptors suggesting a differential influence on neovascularization process. We hypothesize that ERα? and/or ERβ? play an essential role in regulating gene programs mediating vessel homeostasis during chronological aging. To address our hypothesis, we have proposed three aims. In specific aim 1, we will characterize the skin microvasculature in ERα? -/-, ERβ? -/- and 12ERKO mice. Since the extra-cellular matrix plays an important role in the vascular network, we will analyze the matrix related genes in mice in vivo in specific aim 2.These analyses will allow us to determine the effects of ERα? and ERβ? on ECM production in these animals. In specific aim 3, we will determine the mechanism of ERα? and ERβ? on the interaction between endothelial cells and fibroblasts in vitro, using 3D co-culture system. Based on our preliminary in vivo array data we found a significant decrease of adhesion and junction molecules responsible for the cell-cell contact and cell-cell interaction, which may be modulated by ERα? and/or ERβ?. These studies will allow us a better understanding of the role of estrogen receptors in the regulation of microvasculature during chronological aging.

Public health relevance
PUBLIC HEALTH RELEVANCE: Vascular aging with impaired endothelial cell function, which leads to altered angiogenesis, is recognized as key factor in the etiology of CVD. Moreover, age related cardiovascular and cerebrovascular diseases represent a major public health concern for elderly women. The prevalence of cardiovascular diseases (CVD: Stroke, hypertension, heart failure) in males and females was ~73% at age 60-79. However, it was higher in females (~86%) than in males (~80%) at age>79 {(NHANES: 2005-6)-source NCH, NHLBI}. Recently published data have shown that cardiovascular and cerebrovascular diseases were the first and third leading cause of death for those of age >65 respectively (Morbidity & Mortality: 2007 Chart Book NHLBI). Furthermore, morbidity increased 32- 48% for those 66-85yrs of age. We believe that the proposed study of ER1 or/and ER2 deficiency in the mouse model will elucidate the mechanism of altered angiogenesis. This may lead to future discovery of a new therapeutic intervention for cardiovascular and cerebrovascular diseases. Vascular aging with impaired endothelial cell function, which leads to altered angiogenesis, is recognized as key factor in the etiology of CVD. Moreover, age related cardiovascular and cerebrovascular diseases represent a major public health concern for elderly women. The prevalence of cardiovascular diseases (CVD:Stroke, hypertension, heart failure) in males and females was ~73% at age 60-79. However, it was higher in females (~86%) than in males (~80%) at age>79 {(NHANES: 2005-6)-source NCH, NHLBI}. Recently published data have shown that cardiovascular and cerebrovascular diseases were the first and third leading cause of death for those of age >65 respectively (Morbidity & Mortality:2007 Chart Book NHLBI). Furthermore, morbidity increased 32- 48% for those 66-85yrs of age. We believe that the proposed study of ERα or/and ERβ deficiency in the mouse model will elucidate the mechanism of altered angiogenesis. This may lead to future discovery of a new therapeutic intervention for cardiovascular and cerebrovascular diseases. __SpecificAimsTextDelimiter__ Regulation of vasculature by estrogen receptors during aging in mouse models A. HYPOTHESIS AND SPECIFIC AIMS Angiogenesis (new vessel formation) is a complex process that includes several sequential steps such as detachment of pre-existing pericytes, extracellular matrix degradation followed by endothelial cell migration, tube formation and lastly vascular stabilization by reattachement of pericytes. Steroid hormones are among the factors that have been shown to have influence on this process. In particular estrogen has been suggested to promote new vessel formation (especially collateral vessel formation in ischemic tissues), which could be beneficial in common age-related diseases such as coronary artery disease, peripheral vascular disease, cerebral ischemia and congestive heart failure. However, regulatory mechanisms underlying the action of estrogen on endothelial cell function and angiogenesis are not fully understood. The action of estrogen is mediated through the estrogen receptor α (ERα) and/or estrogen receptor β (ERβ). We investigated the role of estrogen receptors in neovascularization using female ERα and ERβ knockout mice. Injection of FITC-dextran revealed blood vessels with irregular diameter and track in ERα as well as in ERβ knockout mice. These results correlated with reduced levels of pericyte markers (α-smooth muscle actin and desmin) in dermal microvessels of ER¿ and to a lesser degree in ER¿ knockout mice as compared with control animals. Furthermore, mRNA levels of numerous genes regulating stabilization of neovessels including PDGFB, VE- cadherin, N-cadherin were downregulated in cultured endothelial cells isolated from ER¿-/- mice, while such analysis has not yet been performed in endothelial cells of ER¿-/- mice. Additional analyses of the whole skin punches obtained from the both ERα-/- and ERβ-/-mice were performed. Interestingly, we observed altered expression levels of two potential modulators of angiogenesis, Lumican (Lum) and Decorin (Dcn) in the knockout mice. The mRNA levels of these small leucine-rich proteoglycans (SLRP's) were decreased in the skin of ER¿-/- mice, while these proteoglycans were increased in the skin of ER¿-/- mice. The different level of SLRP's in the skin of ERα-/- and ERβ-/- mice indicate an opposite regulation of these matrix components by estrogen receptors and may suggest a differential influence on neovascularization process. Taken together, these studies suggest that lack of ERα and/or ERβ lead to dysfunction of endothelial cells and subsequent vessel degeneration simultaneous with deregulation of selected matrix components. We hypothesize that ERα and/or ERβ play an essential role in regulating gene programs mediating vessel homeostasis during chronological aging. To test this hypothesis and to gain additional insight into the regulatory role of ERs we propose the following specific aims: Aim 1. To determine the role of ERα and ERβ deficiency on the vascular network in mice in vivo during chronological aging Aim 2. To determine the effects of ERα and ERβ on extracellular matrix (ECM) production in mice in vivo during chronological aging Aim.3 To determine the mechanism of ERα and ERβ deficiency on the interaction between endothelial cells and fibroblasts in vitro